Addressing Alcohol Use Health Disparities in Latinx Sexual Minorities: A Culturally Congruent Motivational Intervention Targeting Intersectional Forms of Discrimination

PROJECT SUMMARY
Latinx sexual minorities, who are living at the intersection of two NIH identified health disparities groups, are at
increased risk for binge drinking behavior and alcohol-related problems which has been linked to the
intersectional forms of discrimination they experience – racism and heterosexism. Currently there are no
alcohol misuse behavioral health interventions that address the unique need and intersection of identities for
Latinx sexual minorities. There is one promising intervention, Culturally Adapted Motivational Interviewing
(CAMI), that has shown efficacy in decreasing alcohol misuse within Latinx individuals. Specifically, CAMI is a
tailored intervention for Latinx individuals which targets acculturative stress and has shown strong promise in
its reduction of alcohol misuse. Yet, CAMI only address singular forms of discrimination and does not use an
intersectionality and LGBTQ affirming perspective to address multiple forms of discrimination. Therefore, CAMI
will be adapted using an LGBTQ affirmative model of intervention adaptation, informed by minority stress, to
develop an intervention that addresses intersectional forms of discrimination to target alcohol misuse among
Latinx sexual minorities called- Latinx Queer Adapted Motivational Interviewing (LaQAMI). LaQAMI will be
delivered via telehealth, it will be available in English and in Spanish, and traditional motivational interviewing
will be used as the controlled condition. The study will be conducted in New England (NE) and in the
Southwest (SW in Arizona) to account for geographical differences given the diversity of Latinx sexual
minorities. The study will be conducted in three phases: in-depth qualitative interviews with Latinx sexual
minorities (n=20) and clinic stakeholders from NE and the SW (n=10; aim 1) to capture intersectional forms of
discrimination and links to alcohol misuse and receive feedback on the adaptation of the manual; the second
phase will be open series where it will focus on examining feasibility and acceptability of the intervention and it
will be tested with 16 Latinx sexual minorities (n= 8 from NE; n= 8 from SW) and feedback will be incorporated
into the treatment protocol (aim 2); the third phase will be a pilot randomized controlled trial (RCT) with 60
Latinx sexual minorities with 30 participants from NE and 30 participants from the SW (15 receiving the new
intervention and 15 receiving MI from each region; aim 3). The goals of the current study are consistent with
NIAAA’s identified special populations and strategic plan. Additionally, the current K23 will build on the
applicant’s expertise in health disparities, minority stress, and quantitative skills and it will provide the applicant
with advanced training in cultural adaptation, community-engaged research, conceptualizing and executing
RCT’s, and qualitative and mixed methods research. The K23 training period will provide the applicant with the
needed protected time and training to become a leading health disparities researcher focusing on diversity and
addiction science.

Public health relevance
PROJECT NARRATIVE The current study aims to develop an intervention that will address alcohol misuse within Latinx sexual minorities by targeting intersectional forms of discrimination (i.e., racism and heterosexism) as there are no behavioral health interventions that address the unique needs of Latinx sexual minorities within the context of alcohol misuse. The study will adapt a Latinx focused motivational interviewing intervention (Culturally Adapted Motivational Interviewing [CAMI]) using an LGBTQ-affirmative intervention adaptation model to develop a culturally-congruent intervention, with community partnerships, to conduct a pilot randomized controlled trial. Findings will provide initial evidence for a novel intervention to decreases alcohol-related problems and misuse for Latinx sexual minorities.